AVIVA Chatbot 2.0 integration for enhanced communication

Summary of Proposed Research
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-24-039. The proposed research project builds on the AVIVA-AI: A Mentored Approach to
Building Artificial Intelligence Capacity NOT-CA-22-036, a supplement of a parent U01 grant titled
Community, Home-based Education, Screening Services (CHESS) U01 study which focuses on
increasing HPV screening.
AVIVA app has been extensively used for three years, among healthcare workers in 5 states in Nigeria to
provide a higher-level expert review of VIA stained cervix visual image for improved screening diagnosis
in the country, and its implementation process has been reported in BMC Global Health Journal. The app
has assisted in improving diagnosis accuracy among the lower cadre of healthcare workers in lower-level
facilities in Nigeria. The AIVIVA-AI supplemental research project (NOT-CA-22-03) focused on adding
chatbot integration into the AVIVA application to improve awareness of cervical cancer screening
modalities, follow-up, treatment, and behavioral change activities among WLWH and those who treat
them. The study investigators, through this supplement, were able to build a local dataset of 130 unique
questions and concerns of WLWH and virtual healthcare providers’ responses on cervical cancer services
(CCS) and management and take the questions through a series of gynecological expert validation for
response appropriateness and exhaustiveness. While the unique questions might be representative of the
target population's opinions, questions, and concerns on CCS, if integrated directly into a simple AVIVA
chatbot app, it will be limited in catering to the inherent variability in the individual writing style that
might reflect in the way similar questions are asked by WLWH. This automatically affects the chatbot
response efficiency when scaled up to a larger WLWH population. The generative AI-powered chatbot
can handle complex inquiries without the need for human intervention. It has human-level creativity
ability to generate ideas on a possible wide range of questions based on learnings from previously
collected data and adapt to new situations to respond to inquiries of chatbot users. It detects patterns in
large data sets and improves people’s and technology's overall efficiency. This proposed supplement will
focus on training, evaluating, and integrating a customized large language models (LLMs) based
question-answering generative AI engine into the existing AVIVA-AI chatbot app for improved efficiency.
The mentee whose strength is in the cervical cancer program and epidemiological modeling, has
identified international experts and resources to build a generative- AI model into the AVIVA-AI chatbot
to improve the chatbot efficiency for future responsiveness and scalability. He will also be working with a
Nigeria AI programmer to facilitate generative AI knowledge transfer across borders and train a
conversational model in Nigeria using the resources available at large US institutions like Emory
University.

Public health relevance
Project Narrative AVIVA Chatbot 2.0 integration for enhanced communication is a supplement of a parent U01 which focuses on increasing HPV screening access among WLWH. It aims to train, evaluate, and integrate a customized large language models (LLMs)-based question-answering generative AI engine into an existing AI chatbot that is designed to respond to questions, and clear doubts of WLWH about cervical cancer screening (CCS) in three HIV clinics in Nigeria, as a measure to improve CCS access. The generative AI has human-level creativity ability to generate ideas on a possible wide range of questions based on learnings from previously collected data and its integration enables a chatbot to cater to inherent variability and linguistic variations in the way chatbot end users ask the same questions.